Equipment and Instrument Infrastructure Improvement for the MMRRC at UC Davis

Equipment and Instrument Infrastructure Improvement for the MMRRC at UC Davis
ABSTRACT & SCOPE OF WORK
The Mutant Mouse Resource and Research Center at the University of California, Davis (MMRRC) is pleased
to submit this administrative supplement for up to 1 year of support in response to ORIP's participation in PA-
20-272, “Administrative Supplements to Existing NIH Grants and Cooperative Agreements” specifically related
to support alterations and renovations (A&R) of facilities and/or purchase of instruments and equipment in
support of non-AIDS research. This application proposes the purchase and installation of equipment and
instrumentation to ensure and increase the quality, rigor, and capability of husbandry, production, and
phenotyping of mutant mouse lines maintained and distributed by the MMRRC. Specifically, this application
requests funds to improve operations, serviceability, functionality and capability of our MMRRC facilities by 1)
replacing broken and irreparable cryorecovery and analytical instrumentation and to enable off-site storage of
the MMRRC germplasm cryoarchive, 2) upgrading existing animal transfer stations to substantially improve the
quality of specific pathogen-free (SPF) husbandry for MMRRC mouse strains, and 3) obtaining and
incorporating specialized instrumentation and equipment to facilitate new and implement improvements in
musculoskeletal, pulmonary, and behavioral phenotyping capabilities that add substantively to research
integrity, rigor, and reproducibility. Funding of this project will accomplish 5 things. First, it will significantly
improve cryorecovery and IVF efficiency, thus accelerating the availability and facilitating the rapid
dissemination of mouse lines to requesting investigators. Second, it will expedite quality control analysis of the
reproductive biology of MMRRC mouse strains, adding valuable information to users regarding sperm
phenotype and ensuring their recovery from the cryoarchive. Third, it will dramatically improve the quality of
husbandry and health care for MMRRC mice and provide allergen containment to protect vivarium staff.
Fourth, it will enable the validation and depth of phenotyping that can be conducted on all MMRRC mouse
strains, thus directly responding to users' requests for more extensive and comprehensive testing and analysis.
Fifth, it will improve rigor, reproducibility, and transparency in production and phenotyping activities, further
supporting efforts by the MMRRC to achieve approved vendor status by institutions across the country.
Together, these upgrades will significantly enhance our ability to meet the increased expectations of MMRRC
clientele for fully comprehensively validated mouse models and optimize production and phenotyping services.
Further, because these upgrades are MMRRC-project specific, they are beyond the support provided by the
UC Davis campus for basic operations and maintenance. The overall outcome of this supplement will be to
exert a sustained and powerful influence on operations of the MMRRC by improving and expanding its
capability to more expertly maintain, manage, and characterize genetically-modified mouse strains and meet
the needs of the national biomedical research community conducting NIH-funded research. By doing so, this
supplement will provide a sustained benefit to the overall research community and have a positive impact on
NIH-funded research. The parent peer-reviewed NIH funded grant (U42OD012210) has been competitively
renewed (as of January 1, 2020) for 5 years. A budget of $478,325 (total costs) requested for the remaining
months of the current grant year (until January 31, 2024) is less than half the annual total direct cost budget of
the parent grant. The proposed activities all fall within the scope of the parent award, which includes archiving,
phenotyping, and distributing investigator-derived and Center-produced mutant mouse lines.

Public health relevance
Equipment and Instrument Infrastructure Improvement for the MMRRC at UC Davis PROJECT NARRATIVE This proposal from the Mutant Mouse Resource and Research Center (MMRRC) at UC Davis seeks to address a number of the stated objectives of the call to support alterations and renovations (A&R) of facilities and/or purchase of instruments and equipment in support of non-AIDS research in response to NIH PA-20- 272, Administrative Supplements to Existing NIH Grants and Cooperative Agreements. Specifically, this application requests funds to 1) replace broken and irreparable cryorecovery and analytical instrumentation and enable off-site storage of the MMRRC germplam cryoarchive, 2) upgrade existing animal transfer stations to substantially improve husbandry for MMRRC mouse strains, and 3) obtain specialized instrumentation for musculoskeletal, pulmonary, and behavioral phenotyping to enhance capabilities for characterizing mutant MMRRC mice and promote research integrity, rigor, and reproducibility. Doing so will increase the capability and services of the MMRRC for meeting the needs of the biomedical research community conducting NIH- funded research.